Immunosuppressive mechanisms of intratumoral regulatory T cells

PROJECT SUMMARY
Immune-based cancer therapies have revolutionized the treatment of cancer. However, immunosuppression
within tumors remains a major obstacle for their success. Regulatory T cells (Tregs), an immunosuppressive
subset of CD4+ T cells, are heavily recruited to most tumors where they may suppress antitumor immune
responses directly within tumors. Tregs may also impose immunosuppression directly in the lymph nodes draining
the tumor (tdLN), limiting T cell priming events that generate robust and potent antitumor T cells. Where Tregs
function, in the tumor, tdLN, or both, is of critical importance for Treg-targeting cancer therapies because
disrupting Tregs systemically will be highly toxic, whereas selectively targeting intratumoral Tregs (IT-Tregs), if
effective against cancer, would treat cancers without autoimmune toxicities. Our objective is to decipher whether
blocking Treg function in tumors is sufficient for tumor control and to uncover the mechanisms of IT-Treg
immunosuppression. We hypothesize that Tregs function directly within tumors to suppress antitumor immune
responses by reducing the capacity of dendritic cells (DCs) to endocytose tumor antigen, thereby also reducing
T cell priming in the tdLN. Here we propose to investigate this hypothesis by studying experimental and
therapeutic methods of IT-Treg ablation, which appear to effectively control primary tumors as well as untreated
metastases without inciting autoimmunity. In this proposal we will investigate the mechanism of Treg control of
DC antigen uptake (Aim 1), how altered antigen uptake locally in tumors enhances systemic immunity to
metastases (Aim 2), and test whether therapeutically translatable Treg-depleting antibodies delivered
intratumorally can also increase DC antigen uptake and promote systemic immune control of metastatic cancer
(Aim 3). Our findings will uncover new genetic targets to prevent Treg suppression of DC priming of antitumor T
cells without autoimmune toxicity.

Public health relevance
PROJECT NARRATIVE Regulatory T cells (Tregs) are key stabilizers of immune homeostasis, but in cancer, they impede the effectiveness of cancer immunotherapies. While removing Tregs may support better cancer immunity, because of their essential role in immune homeostasis, autoimmunity is a serious side-effect. The identification of methods to selectively target only Treg functions in tumors, if effective, may overcome this obstacle. Here we will investigate a novel mechanism of Treg immunosuppression, inhibition of DC tumor antigen uptake, and test whether selective disruption of this immunosuppressive mechanism can support improved systemic immunity against primary and metastatic cancers.